Innovative multimodal and attention training to improve emotion communication in Veterans with TBI and PTSD

Background. Deficits in emotion recognition are common in traumatic brain injury (TBI) and in post-traumatic
stress disorder (PTSD) but these deficits have not been well studied in Veterans with both mild TBI (mTBI) and
PTSD. Poor emotion recognition has been associated with poor quality of interpersonal relationships, loss of
employment, behavioral problems, reduced social reintegration, social isolation and even suicide. Currently
there are no interventions for emotion recognition deficits in Veterans with mTBI and PTSD, and interventions
conducted in civilians with severe TBI have lacked training of both facial and vocal emotion recognition. In a
preliminary study of an innovative combination of facial and vocal modalities, a multimodal affect recognition
training (MMART) showed promise with significant improvement on the Florida Affect Battery (FAB) but lacked
attention training that is an essential component in recognizing rapidly changing emotions in our everyday
lives. Attention training using Brain HQ™ targets the required attention factors underlying emotion recognition.
Given the need to improve relationships and productivity in Veterans with mTBI and PTSD, a randomized
controlled trial is needed to determine the effectiveness of an innovative MMART combined with attention
training to improve emotion recognition and everyday function.
Objective & Hypotheses. The objective of this randomized controlled trial is to determine the treatment effect
of a MultiModal Affect Recognition Training (MMART) combined with attention training in Veterans with
TBI/PTSD.
Hypothesis 1. MMART combined with attention training will significantly improve performance on tests of
emotion recognition.
Hypothesis 2: Treatment gains will translate to functional activities.
Primary measures. Florida Affect Battery (FAB) and the Community Reintegration in Service members (CRIS).
Secondary measures. Emotion Recognition Task (ERT), attention index of the Repeatable Battery for the
Assessment of Neuropsychological Status (RBANS), the Continuous Performance Task and the TBI Quality of
Life (TBI-QOL) Ability to Participate in Social Roles and Activities.
Methods. 20 Veterans with mTBI and PTSD will be randomized to either the combined training or an inactive
control group. Both groups will attend 16, one-hour in-person sessions over 8 weeks. Outcomes will be
assessed at pre-, post-, 3 month-post-treatment. A linear regression will be used to determine significant
improvement of the treatment group over the control group, with t-tests to demonstrate within group
improvement. Effect size calculations will be used to determine the power needed for a future Merit proposal.
Significance. This study uses a novel combination of an innovative treatment, MMART+ Attention Training to
restore the emotion recognition and attentional processes required for effective emotion communication in
Veterans with mTBI/PTSD. This work meets a key VA RR&D priority of providing quality care to Veterans.
Positive study results will guide the development of a future Merit to improve the quality of life for Veterans with
emotion recognition deficits.

Public health relevance
Poor emotion recognition has been associated with poor quality of interpersonal relationships, loss of employment, behavioral problems, reduced social reintegration, social isolation and even suicide. Deficits in emotion recognition are common in traumatic brain injury (TBI) and in post-traumatic stress disorder (PTSD) but these deficits have not been well studied in Veterans with both mild TBI (mTBI) and PTSD. Currently there are no interventions for emotion recognition in Veterans with mTBI and PTSD, and interventions for severe TBI have lacked training of both facial and vocal emotion recognition. In a preliminary study of an innovative combination of facial and vocal modalities, a multimodal affect recognition training (MMART) showed promise but lacked attention training that is an essential component in recognizing emotions in our daily lives. Given the need to improve relationships and productivity in Veterans with mTBI and PTSD, a study is needed to determine the effectiveness of a MMART combined with attention training.